Physician Postdoctoral Research Training in Perioperative Medicine (PPRTPM)

Physician Postdoctoral Research Training in Perioperative Medicine (PPRTPM): More than 53,800
anesthesiologists practice in the US, but only a small number are physician-scientist researchers. As of
12/31/23, only 215 MD or MD PhD anesthesiologists were PI on an active NIH grant. Nevertheless,
anesthesiology is a requisite component of every medical center, hospital and outpatient surgical facility
because of the 40 million surgical procedures performed annually. Advances in pharmacology, neuroscience,
immunology, biotechnology, and informatics used in interventional/procedural medical care make the field of
anesthesiology/perioperative medicine rich with research career development opportunities. The goal of this
program is to address the as yet unmet need to train more committed physician-scientist anesthesiologists.
PPRTPM program direction, aims and objectives: Program leadership will be provided by Drs. Max Kelz
and Roderic Eckenhoff serving as multi-PD/PIs, with further leadership provided by additional Executive
Committee members Drs. Greg Corder, Meghan Lane-Fall, and Alex Proekt. All are members of the University
of Pennsylvania Department of Anesthesiology and Critical Care. Their responsibilities will be focused on
directing three theme-based research training tracks, two of which are devoted to laboratory research trainees
and the other is devoted to health services research trainees focused on perioperative medicine.
The aims of the PPRTPM are to:
• Identify, recruit and foster research trainees, both anesthesiology residents and clinical sub-specialty
fellows willing to commit to training and career development in perioperative medicine research
• Match up trainees’ strengths and interests with mentoring teams
• Provide guidance for structured learning opportunities
• Maximize the opportunities for mentored research and career mentoring
The objectives of the PPRTPM are to:
• Train a cadre of committed physician-scientist anesthesiology researchers to advance perioperative
medicine research.
• Provide these individuals with the skill sets and foundation for career advancement
• Encourage leadership and innovation
PPRTPM goals—to pursue the aims and objectives through a training program consisting of:
• Didactic opportunities, including core requirements and courses designed to provide research skills
• Seminars, workshops and a journal club focusing on research and progress in the field
• Mentoring with a team approach, mentor training and scholarship oversight
• Programmatic interactions with mainstream research through local/national professional interactions

Public health relevance
Public Health Relevance Statement Over 40 million anesthetics are annually delivered to patients in this country. The proposed program will train anesthesiology/perioperative medicine physician-scientists to be researchers, whose goal will be to advance and improve care in anesthesiology/perioperative medicine for recipients of healthcare in the United States.